Neural circuit mechanisms in social extinction of conditioned place avoidance

PROJECT SUMMARY
Excessive fear and avoidance is a hallmark of anxiety disorders including post-traumatic stress disorder and
special phobia. Social support is commonly used in anxiety-disorder therapies to facilitate extinction of fear or
avoidance. However, how neural activities inside the brain give rise to the social effects on extinction is unknown.
Here we propose to study the underlying neural circuits in rats performing a specially designed behavioral task,
called social extinction of conditioned place avoidance. In this task, a rat fear-conditioned to a shock-zone in an
open arena learns from a conspecific rat that the place is no longer aversive, leading to a reduction of avoidance
to the shock-zone. We will focus on the hippocampus (HP), given its key role in place coding and fear extinction,
and the anterior cingulate cortex (ACC), given its crucial role in social learning. By conducting high-density
tetrode recordings of HP and ACC neurons during this task, we will test a functional model that specifies how
these neurons computationally contribute to social extinction of place avoidance. We will focus on how the
hippocampal spatial representation of the shock-zone is activated by a social subject and how the ACC activities
responding to the aversive experience at the shock-zone are dynamically altered during the extinction. In
addition, we will determine a causal link between the HP and ACC neural activities and the social extinction
behavior by closed-loop electrical and optogenetic manipulations. The outcomes of this study will provide a
specific neural circuit mechanism for how social extinction is achieved inside the brain. The knowledge generated
in this study may inspire novel strategies for better social support or intervention in anxiety disorders.

Public health relevance
PROJECT NARRATIVE This project studies neural activities underlying social extinction of avoidance, a phenomenon that the behavior of avoiding an aversive object or place can be reduced by another social subject. Its outcomes will advance our understanding of neural circuit mechanisms in social extinction and potentially inspire novel strategies for better social support and intervention in anxiety disorders including post-traumatic stress disorder and special phobia.